Structure-Based Designs of HIV-1 Immunogens Targeting Germline Precursors of Broadly Neutralizing Antibodies

PROJECT SUMMARY/ABSTRACT
Broadly neutralizing antibodies (bNAbs) are likely to be an important component of an HIV-1 vaccine. The HIV-
1 Envelope (Env) glycoprotein is the sole target of bNAbs and has been a focus of immunogen designs. Yet
diverse recombinant (rec) Envs do not display detectable binding to the inferred germline (gl) of certain bNAbs,
such as the VRC01-class bNAbs, which are the focus of this proposal. Rec Envs capable of binding glVRC01
bNAbs have been designed and induced the production of glVRC01 bNAbs when used as immunogens.
However, these novel immunogens are not sufficient to induce the maturation of glVRC01-class bNAbs to their
broad neutralization forms. Here we propose to use novel reagents as immunogens to guide the development
of VRC01-class bNAbs by: 1) immunizing knock-in mice with immunogens harboring short glycans to evaluate
if these could more efficiently prime immune responses that will accommodate the HIV-1 Env glycan shield and
2) combining immunological and biophysical (including atomic level structures) characterization. We
hypothesize that such immunogens will already know how to accommodate short glycans and thus be more
amenable to maturation. Our preliminary data show that such antigen has increased binding to precursors
glVRC01-like antibodies. The sequencing of monoclonal antibodies (mAbs) along with structural information
will provide molecular details on the interactions between the vaccine-elicited antibodies from animals and the
immunogens: better understanding the epitopes targeted by the novel vaccine-elicited mAbs will help us identify
the best boost immunogen for future immunizations studies and thus guide HIV-1 vaccine design.

Public health relevance
PROJECT NARRATIVE HIV-1 is a deadly virus against which a vaccine is urgently needed. This proposal will focus on determining if germline targeting immunogens harboring short glycans will more efficiently accommodate the HIV-1 Env glycoproteins glycan shield and on using structure-based design to create improved immunogens. This research plan ultimately aims to inform ontogeny-based HIV-1 vaccine approach.